NIDA DATA, STATISTICS, AND CLINICAL TRIAL SUPPORT CENTER MANAGEMENT AND SUPPORT. 03/01/2020 - 02/28/2021. N01DA-19-2250. TASK ORDER 75N95020F00001 (TO

NIDA DATA, STATISTICS, AND CLINICAL TRIAL SUPPORT CENTER MANAGEMENT AND SUPPORT.